Oxidative Stress, Hormones and Women s Health

The BioCycle Study was a prospective longitudinal cohort study comprising 259 women aged 18 to 44 years (98% follow-up rate) followed for two menstrual cycles (2005-2007). The study was designed to better understand menstrual cycle function and the intricate relationships between reproductive hormone levels and oxidative stress. Since completion of the study, much progress has been made in the analysis of the BioCycle Study data. To date, over 80 papers have been published. The BioCycle Study has contributed substantially to the fields of nutritional, environmental, and social epidemiology, offering valuable insights into various factors associated with premenopausal womens reproductive and cardio-metabolic health. In particular, several physiologic and behavioral factors were recently evaluated with regard to their associations with reproductive hormones and menstrual cyclicity, as well as ovulatory function. Dr. Mumfords team found that markers of vitamin D metabolism (PMID: 33864070), and oxidative stress but not antioxidants (PMCID: PMC7851915), were associated with select symptoms of premenstrual syndrome. Further, low intake of vegetable protein (PMID: 33735390) was associated with hormone levels and a higher risk of anovulation, highlighting the potential role of dietary factors to influence ovulatory function in reproductive-aged women.

Overall, this body of work has been influential in describing not only the short-term impact of diet and lifestyle on hormonal function and markers of menstrual cycle dysfunction (e.g., anovulation, luteal phase deficiency, and abnormal menses) but their potential long-term impact on chronic disease risk. The team intends to build upon its current findings from the BioCycle Study to fill critical research gaps in its quest to answer important public health questions for women of reproductive age.